DATA SYSTEMS UPDATE, DATA INTEGRATION, AND COMPUTATIONAL APPLICATIONS TO SUPPORT DRUG DISCOVERY AND THERAPEUTICS DEVELOPMENT

Modernization, integration and combined querying of chemical, genomic, transcriptomic, proteomic and other datasets to advance treatments for cancers.